Research Project I - Vesicant-Induced Skin Injury

Research Project 1. Vesicant-induced Skin Injury
Key personnel:
Jeffrey D. Laskin, Ph.D., Distinguished Professor, Rutgers University School of Public Health
Donald Gerecke, Ph.D., Associate Professor, Rutgers University School of Pharmacy
Laurie Joseph, Ph.D., Associate Professor, Rutgers University School of Pharmacy
Project Summary/Abstract
Mustard vesicants, including sulfur mustard (2,2'-dichlorodiethyl sulfide, SM) and nitrogen mustard
(bis(2-chloroethyl)methylamine, HN2) are cytotoxic blistering agents synthesized for chemical warfare.
Because they contain highly reactive electrophilic chloroethyl side chains, they readily react with cellular
macromolecules like DNA forming monofunctional and bifunctional adducts. By targeting DNA, mustards can
compromise genomic integrity by causing single and double strand breaks. Double strand breaks are
particularly toxic because they disrupt the physical continuity of the DNA duplex. To protect against
genotoxicity following exposure to mustards, cells initiate a DNA damage response (DDR). This involves
activation of signaling cascades including ATM (ataxia telangiectasia mutated), ATR (ataxia telangiectasia and
Rad3-related) and DNA-PKcs (DNA-dependent protein kinase, catalytic unit). Signaling induced by the DDR
leads to the recruitment and activation of repair related proteins such as phospho H2AX and phospho p53 to
sites of DNA lesions. As a transcriptional activator, p53 can also induce DNA repair proteins, it can also
interact with many signaling pathways including those important in cell cycle control and apoptosis. Excessive
DNA modifications by mustards can overwhelm DNA repair leading to cytotoxicity and tissue damage. Herein
we will investigate DDR signaling pathways induced by mustard vesicants in human keratinocytes and in
mouse skin. Two FDA approved drugs, Enoxacin and Amifostine, reported to enhance DNA repair, will be
analyzed for their ability to enhance DDR signaling in keratinocytes. Investigations into mechanisms by which
Enoxacin and Amifostine enhance DNA repair and potentially protect against cytotoxicity may lead to the
development of a novel class of mustard countermeasures.